The neuronal circuits of affective itch

Chronic itch accompanies many skin diseases as well as systemic diseases and
significantly decreases patients' quality of life. The majority of patients with chronic itch
complain of aversive components of itch such as anxiety that are thought to be triggers or
enhancers of itch. In this application, we will investigate the neuronal circuit of affective itch.
In our preliminary data, we have confirmed activation of the neuronal circuit for anxiety (e.g.,
lateral parabrachial nucleus (LPB), amygdala, midcingulate cortex (MCC), and medial
prefrontal cortex (mPFC)) following intradermal injection of pruritogens in mice. Aim 1 will
characterize anatomical and physiological properties of itch-signaling amygdala neurons
using immunohistochemistry as well as in vivo single unit recording. Aim 2 will investigate
whether the projections from the LPB to the central nucleus of the amygdala and from the
mPFC and MCC to the basolateral amygdala modulate itch and anxiety. Behavioral and
electrophysiological properties of these amygdala neurons will be determined during
optogenetic activation of somata of these projections. Aim 3 will evaluate whether
optogenetic inhibition of itch-signaling amygdala neurons can recover itch and anxiety in a
mouse model of chronic itch. This novel approach would give us important information
about the role of the affective itch circuit in chronic itch and whether treatments that target
the circuit could improve both itch and anxiety in chronic itch patients.

Public health relevance
Chronic itch is a significant clinical problem that is poorly treated. Patients with chronic itch often display high levels of anxiety, and anxiety is thought to be a trigger or aggravating factor for itch in these patients. This project will investigate the neuronal circuit of affective itch and thereby provide a novel therapeutic strategy for chronic itch.